Novel therapeutics for FSHD

PROJECT SUMMARY
Facioscapulohumeral muscular dystrophy (FSHD) causes lifelong severe disability and is one of the most
prevalent muscular dystrophies, afflicting both children and adults. While major advances in genetics have
strongly implicated the inappropriate expression of a powerful transcription factor, DUX4, and its target
genes in the degeneration of muscle fibers in FSHD, no protective pharmacologic treatments yet exist for
this disease. The University of Massachusetts School of Medicine (UMMS) Wellstone Muscular Dystrophy
Cooperative Research Center is a network of collaborative investigators whose research and training
programs focus on developing novel and effective therapeutics for FSHD. The long-term objectives are to
meet this need through three highly synergistic projects directed toward drug discovery and optimization,
supported by our Cores, collaborators and advisors. Specific Center goals are: 1) identifying FSHD
disease modifiers through expanded genomic investigations of a large Utah FSHD kindred in Project 1 to
discern native gene variants and regulatory pathways that influence the FSHD clinical phenotype; 2)
discovering modulators of DUX4 toxicity in Project 2 using the novel Wellstone FSHD cell and animal
models and CRISPR-based inhibition approaches to identify gene and regulatory pathway therapeutic
targets; 3) optimizing our lead DUX4 RNA therapeutics and DUX4 signaling compounds in Project 3, in
collaboration with industry; 4) partnering with FSHD and patient advocacy groups to support and
participate in FSHD research and clinical trials; 5) expanding collaborations with industry partners who
have tools and experience to develop FSHD therapeutics; and 6) training the next generation of clinician-
scientists and translational researchers, who will be the driving force of our Wellstone therapeutic
development program. Three Center Cores will support the research and training activities of this
Wellstone Center and also the greater FSHD research and patient communities. These include an
Administrative Core to facilitate communication between our investigators at all sites and to connect
investigators with patient advocacy groups, particularly the FSH Society, so that we may continue to
engage and provide education to individuals with FSHD and their families. The Education and Training
Core will continue to oversee the research and clinical training of students and fellows. The Resources
Core will expand a unique repository of FSHD biomaterials, including DNA, muscle tissues, myogenic
primary cells and muscle cell lines derived from biopsies, and iPSC cells derived from patient fibroblasts
to support Wellstone and greater FSHD community research. These materials are available to academic
and industry groups and have increasingly been used as FSHD models for biomarker and preclinical
therapeutic studies. The Resources Core will utilize novel inducible DUX4 mouse and zebrafish models
and a xenograft model that will support our proposed preclinical projects and also will share these models
with other FSHD research groups to accelerate FSHD therapeutic development.

Public health relevance
PROJECT NARRATIVE The University of Massachusetts School of Medicine (UMMS) WellstoneMuscular Dystrophy Cooperative Research Center is a distributed, multi-institutional Center with an exceptional team of collaborative investigators and trainees with multidisciplinary clinical and basic research expertise, whose research and training is focused exclusively on FacioscapulohumeralMuscular Dystrophy (FSHD). Center researchers and their academic and industry partners will utilize the Center’s unique FSHD patient-derived muscle cell and animal model resources and state-of-the-art genomic, molecular genetic and cell biological technologies to identify novel druggable FSHD disease targets and validate already promising therapeutics. The intent of our Center is to initiate IND enabling studies for several compounds over the next five years.